Biological Sciences Program at The Gerontological Society of America's 2022 Annual Scientific Meeting

PROJECT SUMMARY
This proposal requests funding from the National Institute on Aging for the Biological Sciences (BS) Section
Program at the 2022 Annual Scientific Meeting (ASM) of the Gerontological Society of America (GSA) in
Indianapolis, IN. Our aim for BS programming is to highlight the highest-quality aging research with a focus on
New Voices and New Avenues of investigation. We believe that the best work in the field will emerge when basic
researchers exchange information about health-related biology of aging with medical researchers and
practitioners, psychologists, sociologists, and public policy experts. In turn, improvements in clinical care and
public health are likely to result when gerontologists from diverse disciplines better understand basic
mechanisms of aging and are exposed to the latest and best research with the promise of yielding interventions
to ameliorate aging and age-related disease. We in the BS Section take very seriously our responsibility to
expose our members, those of the Biological Sciences and the GSA at large, to well-communicated, cutting-
edge science that ultimately serves to inform and improve the work of all who attend. The ASM is situated
uniquely in the U.S. to promote an interdisciplinary effort of this scope, and the 2022 November meeting in
Indianapolis will provide an outstanding opportunity to expand the diversity of participating scientists. Since 2010,
the BS Section has demonstrated quantifiable success in producing a scientific program of the highest possible
quality and providing a forum to engender interaction and exchange of ideas among scientists from disparate
fields. In November 2022, we propose to intensify and extend our efforts, through a single-track meeting program
featuring emerging concepts in the basic biology of aging; to promote discussion and networking among
attendees across sections; to enact gender balance and diversity in the oral program; and to feature talented
early career investigators prominently in Biological Sciences symposia. In Indianapolis, we will begin with a
National Institute on Aging, Division of Aging Biology sponsored pre-meeting, half-day workshop organized by
Ronald Kohanski and Yih-Woei Fridell. During the main meeting 15 (non-competing) oral sessions will be held.
These sessions were devised by a team of ten Early-Stage Investigators recruited for their expertise and potential
as future leaders in aging research. Each member of the team will Chair a session and will participate in all
aspects of the meeting organization, evaluation, and student engagement, under the mentorship of PI Anderson.
There will also be two poster sessions scheduled so as not to compete with any talks. Along with GSA leadership,
we have devised strategies to recruit underrepresented scientists and support 8 minority scholar awards. Our
program shows 40% of all speakers are Early Stage Investigators, more than half of the invited speakers are
women, and 20% are from underrepresented minority groups.

Public health relevance
PROJECT NARRATIVE The Biology of Aging program at the Gerontological Society of America (GSA) 2022 Indianapolis meeting is organized in accordance with the GSA’s mission to promote interactions between biologists and other scientists of diverse disciplines focused on aging, age-related disease and disability; and the social, psychological, and public policy impacts of an aging society. The goals of the Biology of Aging program are to (1) present cutting-edge advances in biology of aging research that provide new avenues for translation to human well-being and extension of healthy human lifespan and (2) to expand the diversity of scientists actively participating in biology of aging research. Our program shows all of our Chairs are Early Stage Investigators with 50% women, of our speakers 40% are early stage investigators, 58% are women, and 20% are from underrepresented minority groups.